NEUROTRANSMITTER RECEPTORS IN THE NERVOUS SYSTEM

Rat brain neurotransmitter receptors were studied. There were circadian rhythms in neurotransmitter receptors in discrete brain areas circadian rhythm was present in cyclic AMP production in cerebral cortical slices, as a functional response to occupation of Alpha- and beta-adrenergic receptors. There was a circadian rhythm in arginine vasopresser in the suprachiasmatic nuclei.